Role of exosomes in ethanol-induced neurotoxicity

Fetal alcohol spectrum disorders (FASD) include a range of maladies caused by chronic alcohol exposure
during pregnancy. It is documented that approximately 2% to 5% of children born in the United States have
FASD. Clinical studies have shown children and adults with FASD often show hyperresponsiveness to stress
and are vulnerable to psychiatric disorders, particularly mood disorders. The neurobiology of these emotional
disturbances are not well understood, but studies utilizing animal models of fetal alcohol exposure have shown
that prenatal or early-postnatal ethanol exposure in laboratory rats and mice disrupts the hypothalamic-
pituitary-adrenal axis function and its physiological response to stress and promotes anxiety-like behaviors.
Both prenatal ethanol exposure and postnatal ethanol exposure induce hypothalamic proopiomelanocortin
neuronal death and reduce levels of proopiomelanocortin and its peptide product β-endorphin, as well as the β-
endorphin peptide's inhibitory control of the hypothalamic-pituitary-adrenal axis function. Replenishment of β-
endorphin neurons via neuronal transplantation prevents stress and behavioral problems in fetal alcohol-
exposed
animals, indicating that β-endorphin deficiency is a significant contributor to the stress and behavioral
abnormalities in these animals. The mechanism by which β-endorphin neurons experience apoptosis following
fetal alcohol exposure is not well understood. There are several preclinical and clinical evidences that
suggest microglia, one of the immune cells in the central nervous system, play a major role in the regulation of
alcohol-induced neuronal damage. Recent studies show that inflammatory cytokines can be released in
association with small extracellular vesicles, called exosomes, from microglia. These exosomes are comprised
of a lipid bilayer, transmembrane proteins, and cytosolic components derived from their host cells. However,
the role of microglial exosomes in alcohol-induced neurotoxicity has not been well studied. In this proposal, we
propose to determine if microglia use exosomes to induce ethanol-induced β-endorphin neuronal death and
stress axis functions. We also propose to use proteomic and genomic measurements to identify if ethanol
treatment during the postnatal period increases levels of chemokines, complements, and microRNAs in
microglial exosomes. Additionally, we propose to identify the exosome biomolecules that have apoptotic effects
on β-endorphin neurons. Together these studies should establish how prenatal ethanol modifies contents of
proteins and genes within exosomes to induce β-endorphin neuronal apoptosis that may lead to stress axis
hyperresponsiveness and increased anxiety behavior. Additionally, the proposed studies may identify a novel
therapeutic approach to prevent some of the neurological problems that occur in FASD patients.

Public health relevance
Fetal alcohol exposure can lead to neurotoxicity associated with structural and functional damage to the brain. It is crucial to elucidate mechanisms of neurotoxicity in order to develop effective therapeutic strategies. Our proposed study will determine a novel mechanism of ethanol-induced β-EP neuronal toxicity involving microglia-derived exosomes and chemokines, complements and miRNAs.